Metabolic adaptation in residual triple negative breast cancer following chemotherapy

PROJECT SUMMARY
TNBC is a subtype of breast cancer predominated by major health disparity. African American (AA) women
have a disproportionately higher incidence of TNBC than do European American (EA) women. In fact, AA
women are twice as likely to be diagnosed with TNBC as are women of other races. Within TNBC, AA women
have significantly poorer outcomes than EA women. In fact, the poorest outcomes in TNBC are for AA women
with late-stage TNBC, having an abysmal five-year survival rate of only 14%. It is well established that a
complex interplay of biologic (e.g., germline genetic features, oncogenic gene expression, and tumor
microenvironment6 features) and non-biologic (e.g., socioeconomic disadvantages, societal stresses, and
associated comorbidities such as obesity) factors underlie this disparity. As described above, our parent R37
focuses on molecular mechanisms of TNBC chemotherapy resistance. Notably, AA TNBC patients have higher
rates of chemo-refractory disease and lower rates of chemo-sensitive disease compared to other ethnic
groups7. The biological underpinnings of this disparity within TNBC are not understood. Our work has helped
establish the key role of tumor cell mitochondrial structure and function in TNBC chemoresistance, and this has
been recently affirmed by our collaborative teams’ large-scale patient8 and PDX9 datasets. However, this
finding has not yet been placed into in the context of racial disparity. Based on our findings that mitochondria
are key mediators of chemoresistance and based on the clear racial disparity of chemotherapy responses in
TNBC, we hypothesize that racial disparity in mitochondrial structure and function contributes to the
disparity of chemotherapeutic responses amongst TNBC patients. We will address this new hypothesis in
the below specific aims. We expect that data generated within the scope of this proposed grant supplement will
form a strong foundation for a full R01 proposal focused on mitochondrial network disparities between AA and
EA TNBC, and we expect this knowledge will support mitochondria-targeting therapy development.

Public health relevance
PROJECT NARRATIVE FOR CHD SUPPLEMENT Triple negative breast cancer (TNBC) is an aggressive subtype of breast cancer that is inherently characterized as exhibiting a major health disparity. Women of African descent are disproportionately likely to be diagnosed with TNBC and once diagnosed, have poorer chemotherapy responses and long-term outcomes than women of European descent. Our parent R37 aimed to dissect mitochondrial structure and function in chemoresistant TNBC. Our studies proposed in this supplement will broaden our work to encompass TNBC specimens from African and European descent to compare mitochondrial structure, oxphos, and their role in chemoresistance.